MRI Diffusion in Tumors using Oscillating Gradients

Abstract / Summary
This revised competitive renewal seeks to extend the technical developments of the previous funding
period to validate and apply a novel diffusion-based MR imaging technique, quantitative temporal diffusion
spectroscopy (qTDS), that provides unique information on tissue microstructure and in particular can reveal
early changes in tumors after treatment. In the previous cycle we developed this innovative method and
showed it is a sensitive indicator of changes in cell dimensions and tissue microstructure such as those that
occur with cell division and during apoptosis, before frank changes occur in cell density or tumor volume. As
such, qTDS has considerable potential for assessing whether specific treatment regimens are working, and so
may inform the selection of optimal therapies for patients and the reduction of avoidable side-effects. QTDS is
based on measurements of water diffusion rates over different time scales corresponding to different spatial
dimensions. We have previously shown it can detect changes in intracellular structure and cell sizes and
density, in cell cultures and in animal models, early in the course of a treatment and without some of the
confounding factors that affect other diffusion techniques, such as changes in cell membrane permeability. We
have performed theoretical analyses, computer simulations, and cell and in vivo animal studies, to understand
the factors that affect qTDS measurements, and have implemented the first practical qTDS acquisitions on a
human 3T scanner. In the current proposal we aim to extend our previous work and use qTDS as an in vivo
imaging technique for non-invasive characterization of specific cellular changes which are currently
assessable only via invasive biopsy. We propose to validate qTDS in cell and animal models of cancer, and
determine whether qTDS is capable of detecting treatment-induced cell size changes early in specific
therapeutic regimens. We also propose to translate qTDS clinically by demonstrating its performance in
predicting neoadjuvant treatment response in breast cancer. We hypothesize that qTDS is capable of
characterizing the distinct cellular changes associated with treatment-induced apoptosis, thereby providing an
innovative and unique means of assessing tumor response at an early stage of therapy. Our specific aims are:
[i] in a transgenic mouse model of breast cancer, we will quantitatively map tumor cell size and density in vivo,
and validate the qTDS derived parameters on a voxel by voxel basis using using quantitative, co-registered
histology: [ii] in mouse models of breast cancer treated by different targeted drugs, we will evaluate qTDS as
an imaging biomarker capable of detecting treatment-induced apoptosis and predicting treatment efficacy
early during therapy: [iii] In human breast cancer patients, we will evaluate qTDS as an imaging biomarker for
assessing breast tumor early response to neoadjuvant chemotherapy and predicting treatment efficacy after
the first and subsequent cycles of treatment by correlating imaging data with clinical and pathological
responses. The proposed qTDS method has the potential to measure cell size changes in vivo and improve
the assessment of treatment response and thereby contribute to personalized clinical cancer care.

Public health relevance
Relevance This proposal aims to validate and apply a novel MRI imaging technique based on measuring the diffusion of water molecules in water over different time scales, from which unique information on tissue microstructure such as cell size and density can be derived. The method is well suited to assess the early response of tumors to treatment and thus to play a currently unfulfilled role in the management of cancer patients. The method will be applied in an ongoing clinical trial of breast cancer therapy and in parallel studies will be validated by studies in mice that will aid the interpretation of the imaging data.